Administrative Core

Project Summary
The Glycoscience Center of Research Excellence (GlyCORE) was established in 2020 to develop a regional
hub of glycoscience excellence in the IDeA state-rich Mid-South region. The Administrative Core provides
administrative services and oversight to all activities of GlyCORE. In Phase 2 of our fifteen-year plan, we will
build upon our progress in Phase 1, focusing on improvement in two identified areas of need: faculty success
rates in extramural funding, and increasing the number of participating faculty. We will support four concurrent
Research Project Investigators throughout Phase 2 to improve the competitiveness of our researchers for major
extramural funding, as well as increase our number of Pilot Projects to nine to develop research ideas from their
initial stages. We will add a new route for support of new glycoscience faculty recruitment to the University of
Mississippi through an alternative application route for the Pilot Project program available to pre-hire recruits.
We will expand our mentorship program and incorporate professional grant proposal review to improve our
investigators' competitiveness for extramural funding in glycoscience. We will also work with our Research Cores
to aid in the development of cost recovery models for our transition to sustainability while using a voucher system
to ensure subsidized access to GlyCORE researchers to better promote faculty development in Phase 2. We
will build upon our progress so far in the first three years of Phase 1 to build a community of glycoscientists in
the Mid-South region, with GlyCORE and the University of Mississippi at its center providing a concentration of
faculty expertise and valuable research infrastructure to the community. By the end of Phase 2, GlyCORE will
be recognized as a major destination for glycoscience in the Mid-South, with a core of faculty expertise and
sustainable research infrastructure necessary to support modern glycoscience.